Design and Analysis Core

Project Summary
The overall goals of the Design and Analysis Core (DAC) are to provide clinical translational neuroscience-­
relevant design and analytic resources to enhance and support COBRE Center for Neuromodulation (CCN)
projects, pilots and cores, and enhance the neuroscience research capacity at Butler Hospital specifically and
in Rhode Island, generally. The DAC will focus on providing support in three research contexts: planning,
support, and training. During planning stages, DAC will assist Project Leaders in crafting research design,
research infrastructure and resource planning, and development of data analysis plans. The goal is to generate
and support feasible designs that support and provide a mechanism to ensure and verify high quality data, and
reproducible data analysis and sound statistical inference. The DAC will provide and coordinate access to and
ensure responsible use of a computational support infrastructure at Butler Hospital that has been designed to
facilitate reproducible data analysis in the clinical neurosciences. The DAC supports its educational mission by
training PLs and their teams in application of computing tools and management of large and complex data. A
unique focus of the DAC is in the planning and design of studies that facilitate clinical translational
neuroscience research, meaning: we assist PLs in planning and analysis of complex and high dimensional
neuroscience data together with clinical (e.g., behavioral) data in order to speed translation of results and more
effectively communicate the clinical importance of the findings. Our long-­term goal is to grow into a resource
that serves the neuroscientists, psychologists and clinicians at Butler Hospital by providing a broad range of
statistical and high-­performance computing services. To support the CCN in achieving its mission, the DAC
has the following specific aims: Aim 1) Support CNN project leaders in the design and analysis;; Aim 2)
Enhance and refine existing computing infrastructure;; Aim 3) Enhance clinical neuroscience research in the
Rhode Island community.

Public health relevance
Project Narrative The Design and Analysis Core (DAC) will facilitate the research goals of COBRE Project Leaders and will benefit the broader neuromodulation research community by developing by ensuring proper experimental design, data management, and analysis procedures across the projects. The DAC was created to address a critical need, namely to provide Project Leaders with design and analysis guidance and supplementary training needed to generate sensible and interpretable neuroscience data. The DAC will provide key input to all three research projects. The DAC will also conduct a series of seminars, workshops, and training modules designed to provide Project Leaders with critical training in project and data management, basic computer science skills.